Teachers and Students for Community-Oriented Research and Education: Linking Industry Partners, Faculty, and Teachers (TSCORE LIFT)

ABSTRACT
21st century changes in the healthcare sector have outpaced changes in science education. High school
students who have the luxury of receiving high quality experiential education are least likely to be from racially,
ethnically, or geographically diverse backgrounds. There is an urgent need to reach students least likely to be
served with culturally responsive, localized science education partnerships, specifically minority and rural
student populations. Without special programming, inequities in educational access will persist, and the
healthcare sector will be ill-prepared for whom it is designed to serve. For the last five years, we have used an
NIH Science Education Partnership Award (SEPA) to address this problem by focusing on teachers as agents
of change. Our prior SEPA (2015-2020), Teachers and Students for Community-Oriented Research and
Education (TSCORE), empowered teachers to engage urban high school students in Kansas through
innovative teaching about health disparities and creation of model units. We found that teachers in
underserved districts lacked the professional development, curricular materials and often depth of knowledge
needed to implement culturally relevant, rigorous NGSS-aligned science curricula. Underserved school districts
are less likely to partner with universities and industry to provide students with opportunities for experiential
learning outside the classroom. And partnerships with industry are key to designing and implementing STEM
educational experiences that meet the needs of a diverse population of students while preparing them for
careers. With these premises in mind, we propose a continuum of educational interventions that are embedded
within the existing structure of the state of Kansas Health and Bio Sciences Career Pathway. “TSCORE LIFT,”
which Links Industry, Faculty, and Teachers in communities, will 1) Create community linkages among health
system, university faculty, and public school teachers to offer a continuum of NGSS-aligned educational
interventions across the state of Kansas Health and Bio Sciences Career Pathway. Each of five Kansas towns
will have a local health system partner, a local K-INBRE university partner, and a public high school, who will
work together to develop NGSS-aligned high school storylines for biology courses; a health science academy
for career exploration; and a capstone course to provide work-based learning experiences that address local
science and healthcare workforce needs. 2) We will empower teachers to work alongside health system and
university partners to develop and implement a curricular continuum of NGSS-aligned localized science
education programming through summer professional development that will mirror the rollout of the science
programming; an end of grant Teacher Summit; and virtual network site to increase teachers' connectivity,
resource exchange, and enable the emergence of a critical mass of practitioners focused on increasing
rigorous health science educational opportunities for underserved students.

Public health relevance
PROJECT NARRATIVE TSCORE LIFT will create a community linkage among 5 health systems, 5 universities, and 5 school districts to develop and test a series of 3 educational interventions along the Kansas Health and Biosciences Career Pathway. The community linkages will empower 25 teacher partners to deliver educational content and real life experiences in the health care industry for 1,400 students. This novel health and bioscience program will create educational and workforce pathways for students underrepresented in the health care industry and address critical workforce shortages in the state in the immediate future.